Understanding and overcoming resistance of breast cancer brain metastases to RET inhibition

Project Abstract
Breast cancer brain metastasis (BCBM) is associated with poor prognoses and dismal survival of 4-6 months
following diagnosis. Management of BCBM remains a major clinical challenge due to inadequate understanding
of the mechanisms underlying BCBM and the lack of drugs with effective blood-brain barrier (BBB) penetration.
Thus, there is an urgent unmet need to identify actionable drug targets for BCBM and develop novel therapies
for treating patients with BCBM. Rearranged during transfection (RET) receptor tyrosine kinase is
hyperactivated in thyroid and non-small cell lung carcinomas (NSCLC); two RET inhibitors, selpercatinib and
pralsetinib received FDA approval in 2020 for treating thyroid cancer and NSCLC. Both RET inhibitors reduced
brain metastases in the NSCLC clinical trials; however, their efficacy in BCBM is still unknown. Since it has been
reported that RET is overexpressed in BCBM and RET inhibitors (selpercatinib and pralsetinib) cross the BBB,
we conducted preliminary studies and found that selpercatinib significantly reduced BCBM incidence when
administered one day following intracardiac inoculation of tumor cells. However, selpercatinib did not significantly
suppress progression of developed BCBM in our treatment mouse model, which suggests the need to identify
pathways/genes that confer the resistance of established BCBM to RET inhibition. To identify pathways co-
activated with RET, we analyzed publicly available breast cancer datasets and found correlations between RET
and truncated glioma-associated oncogene homolog 1 (tGLI1), a known mediator of BCBM progression.
Through chemical screens followed by preclinical validations, a previous study identified FDA-approved
antifungal ketoconazole (KCZ) selectively inhibited tGLI1-driven BCBM in vivo with excellent BBB permeability,
leading to a window-of-opportunity clinical trial with BCBM. Our preliminary studies further revealed that (i)
activated RET and tGLI1 are preferentially co-overexpressed in BCBM tissues compared to matched primary
tumors, (ii) tGLI1 overexpression enhances resistance of brain-tropic breast cancer cells to RET inhibitors in
vitro, (iii) tGLI1 knockdown sensitizes brain-tropic breast cancer cells to RET inhibition, and (iv) RET inhibitors
synergize with KCZ in vitro. Based on these findings, we hypothesize that tGLI1 mediates BCBM resistance to
RET inhibition, and dual targeting of RET and tGLI1 synergistically inhibits BCBM. In this R21 project, we will
determine the role of tGLI1 in BCBM resistance to RET monotherapy (Aim 1), determine if dual targeting of RET
and tGLI1 synergistically inhibits BCBM using intracardiac injection mouse model, and elucidate the pathway
crosstalk between RET and tGLI1 (Aim 2).

Public health relevance
Project Narrative The goal of this proposal is to determine the efficacy and mechanism of action of a novel combination therapy for brain metastases of HER2-enriched breast cancer and triple-negative breast cancer. This goal will be reached through using relevant models of breast cancer, including cell line-derived xenograft mouse models and experimental metastases models. If successful, our project will identify a novel therapeutic strategy for patients with breast cancer brain metastases and provide major advances in breast cancer biology and therapy.